Advanced diffusion MRI for evaluating early response to radiation treatment in cervical cancer

Project Summary
Despite the advent of aggressive cervical cancer screening programs, cervical cancer remains one of the most
common cancers affecting women under age 35, and the fourth most common cause of cancer death worldwide.
The standard of care for early stage (≥IB) cervical cancer is hysterectomy or radiation. Unfortunately, the
consequences of radical treatment include fertility loss, nerve injury causing bladder and bowel dysfunction, and
pelvic pain. There is a critical need to reduce cervical cancer mortality, while minimizing the potential morbidities
of treatment. To achieve this end requires refined approaches for diagnosis and evaluation of response to
treatment using noninvasive biomarkers to differentiate indolent from clinically significant disease at the earliest
possible time-point. PET/CT is currently the mainstay in evaluating response to treatment and is highly
confounded by post-treatment changes such as edema. Magnetic resonance imaging (MRI) with advanced
diffusion-weighted imaging may offer an alternative approach to evaluate treatment response, with additional
advantages of being a radiation-free and contrast media-free exam. The overall objective in this application is to
develop and evaluate a robust advanced diffusion-weighted imaging technique that provides a highly sensitive
and specific reflection of cervical cancer tumor burden and treatment response at the earliest possible time point.
Our hypothesis is that restriction spectrum imaging (RSI), an advanced diffusion imaging technique, is as
sensitive and specific as standard of care post-treatment PET/CT for evaluation of treatment efficacy of cervical
cancer and can be performed 3 months earlier than standard of care PET/CT. The aims of this proposal are 1)
Determine the RSI model for cervical cancer evaluation, 2) Develop and validate a cervical cancer classification
algorithm from multi-parametric MRI based on the Aim 1 biophysical model using established machine learning
techniques, 3) Prospectively validate RSI-MRI compared to PET/CT in evaluating response to radiation
treatment in cervical cancer patients (≥ stage IB) in a pilot study0. The main significance of this study is the
development of a radiation-free and non-contrast imaging technique for evaluating response to treatment three
months earlier than the current standard of care PET/CT. This will allow appropriate treatment earlier preventing
unnecessary progression of disease. The innovation proposed involves developing a diffusion model specific for
cervix imaging within the RSI framework based on the biophysical characteristics of healthy and malignant
cervical tissue. We will then apply this quantitative technique prospectively on a preliminary cohort of patients
before and after treatment and compare to the standard of care PET/CT imaging. At the completion of the study,
a new tool for evaluating response to treatment in cervical cancer that is contrast and radiation free will be
available. This is directly translatable to the clinical setting to benefit cervical cancer patients. Cervical cancer
patients will be better served, particularly patients not responding to treatment, as they can be directed to
appropriate treatment at an earlier time point.

Public health relevance
Project Narrative The proposed research is relevant to public health because cervical cancer is a common cause of cancer amongst women and treatment decisions are based heavily on accurate and early imaging. By developing a technique that evaluates response to treatment earlier than the current standard of care, we will decrease morbidity and mortality by treating cervical cancer at an earlier time point, preventing further progression of disease. The development of new biomedical imaging techniques to fundamentally improve the detection and treatment of disease is directly relevant to one of the key missions of the NIH.